Social Stress Epigenetics and Cardio-Metabolic Health Among Latinos

Latinos, the largest ethnic minority group in the United States, have a high prevalence of hypertension,
diabetes and obesity and also experience higher rates of poverty and social stressors in both childhood
and adulthood compared to other racial/ethnic groups. There is extensive evidence that economic and
social stressors shape the development of cardiometabolic health. However, it is largely unknown how
these stressors affect biological processes, particularly at the cellular level. One novel method to evaluate
possible mechanisms underlying the associations between social stressors and cardiometabolic health
across the life course is DNA methylation (DNAm). Recently a handful of small cross-sectional studies
have found that stressful experiences may alter DNAm, thus providing a potential mechanism by which
social stress may get under the skin. Most of the existing health research among Latinos has been specific
to Latinos of Mexican origin. Latinos are not a homogenous group and while some Latinos are at greater
risk of certain chronic conditions, other Latino groups may be at lower risk for certain conditions. Examining
what factors may confer risk to some Latino ethnic groups or protect other Latino ethnic groups is crucial
for developing interventions and informing decisions about resource allocation. We propose to examine the
association between social and economic stressors, across the life course in relation to DNAm, as well as
the rate of change of methylation and changes in cardiometabolic health, using existing data from the
Hispanic Community Health Study /Study of Latinos (HCHS/SOL). The HCHS/SOL study is a longitudinal
study of US Latinos, representing varied countries of origin, conducted in the US. We propose to use
existing data from a stratified random sample of 500 men and 500 women, who completed an extensive set
of socio-economic and stress measures in the HCHS/SOL Sociocultural Ancillary study and who provided
blood samples at two different time points six years apart in adulthood. Existing blood samples will be
assayed for genome-wide DNAm and DNAm age. Cardiometabolic health markers (obesity, diabetes,
hypertension and lipids) have also been assessed at two time points. Existing data also includes repeated
assessments of social and economic stressors and socio-cultural factors (i.e., nativity, familism,
acculturation, social support). Specifically, we will examine 1) whether social and economic stressors in
childhood and adulthood are associated with changes in DNAm age and genome-wide methylation over a
6-year period; 2) whether sociocultural factors modify the association between stressors and changes in
DNAm and 3) whether DNAm is associated with changes in cardiometabolic health over a 6-year period.
Upon completion of this project, our findings will advance understanding of how social and economic
stressors shape epigenetic pathways, what factors may exacerbate or ameliorate these pathways and
whether epigenetic changes over time influence cardiometabolic health changes.

Public health relevance
Project Narrative Economic and social stressors are increasingly recognized as important factors that shape the development of cardiometabolic health particularly among Latinos, who experience a disproportionate burden of cardiovascular disease. However, particularly at the cellular level, biological pathways through which stress affects health disparities are not fully understood. We propose to address these gaps by examining the independent and cumulative impact of both economic and social stressors across the life course in relation to DNA methylation (e.g. DNA methylation age and genome-wide methylation) among a diverse sample of Latinos living in the US, whether modifying factors relevant to Latino populations may ameliorate or exacerbate this relation as well as how these epigenetic factors may impact cardiometabolic health.